Multidisciplinary Training in Critical Care Outcomes Research

PROJECT SUMMARY
In this application, we propose to continue our highly successful multidisciplinary post-doctoral training
program in critical care outcomes research. The training program provides 2-3 years of research
training in critical illness and acute cardiopulmonary dysfunction with a focus on complex critical
illness syndromes such as acute lung injury and sepsis. The academic home of our training program
is the Center for Research, Investigation, and Systems Modeling of Acute Illness (CRISMA), an
interdisciplinary research center in the University of Pittsburgh Department of Critical Care Medicine.
CRISMA contains over 25 extramurally funded faculty members, 45 research staff members, and core
facilities supporting bench research, prospective data collection, data management, statistical
analysis, project management, and administrative support. Post-doctoral scholars train in one of five
interrelated areas of investigation reflecting the expertise of primary CRISMA faculty: (a) clinical and
translational science; (b) patient-centered outcomes research; (c) systems modelling and
computational biology; (d) critical care ethics and decision making; and (e) critical care organization
and management. In this renewal, we further strengthen our training program by expanding training
opportunities in data science, artificial intelligence, human-computer interaction, critical illness
throughout the lifespan, and advancement of the learning health care system. Training activities
include intensive mentorship in the form of weekly meetings with primary mentors and monthly
meetings with mentorship teams; didactic education in the form of formal coursework in research
methodology through the University of Pittsburgh Institute for Clinical Research Education, in most
cases culminating in the attainment of a master’s degree; and experiential research during which
trainees design, execute, and complete mentored research projects in a thematic area of study. In
addition, trainees present and receive feedback on their ongoing work during weekly lab meetings and
research seminars. All trainees also receive interactive instruction in the responsible conduct of
research and methods for enhancing rigor and reproducibility via both formal and informal activities.
The training environment is supported by numerous career development resources at the University
of Pittsburgh, including tight integration with our University’s Clinical and Translational Research
Institute. Overall, our training program is designed to create an innovative scientific workforce with the
skills necessary to answer the most pressing research questions about critical illness and severe
acute cardiopulmonary disease.

Public health relevance
PUBLIC HEALTH RELEVANCE Over four million Americans are admitted to an intensive care unit each year, and mortality for critical illness syndromes such as acute lung injury and sepsis exceeds 25%. This training program will provide post-doctoral scholars with cutting-edge interdisciplinary training in critical care outcomes research across the translational spectrum, creating a scientific workforce with the skills, experience, and expertise to design and execute research studies that will improve patient-centered outcomes for patients with critical illness and acute cardiopulmonary disease.